Department of Veterans Affairs (VA), Cooperative Studies Program Coordinating Center in Perry Point, MD

The National Institutes of Health, National Institute on Drug abuse, Division of
Therapeutics and Medical Consequences (herein referred to as NIDA) and the
Department of Veterans Affairs (VA), Cooperative Studies Program Coordinating
Center in Perry Point, MD (herein referred to as the CSPCC) shall jointly establish a
clinical trials program for testing of investigational or marketed medications for
treatment and/or prevention of drug abuse and dependency. Each party will provide
resources to ensure that these research studies can be conducted in safe and
scientifically rigorous manners. These efforts may include providing and/or securing the
resources necessary for the administrative and operational support for the conduct of
clinical trials under this Inter-Agency Agreement (IAA) that are not otherwise provided
by the National Institute on Drug Abuse (NIDA). These resources include, the qualified
personnel, facilities, supplies and equipment needed to provide the services. Services
will be performed by personnel at the CSPCC's core facility and by other
persons/entities as designated by NIDA and CSPCC.